Core G - Biostatistics Core

PROGRAM SUMMARY/ABSTRACT
CORE G: BIOSTATISTICS
Data used for HIV research are constantly increasing in complexity, volume and availability. This enables
researchers to investigate myriad questions related to HIV, from the molecular to the population and policy levels,
and often at multiple levels at once. Biostatistical methods and their principled application are therefore
fundamental to rigorous, reproducible HIV research. Core G will provide CFAR investigators with the
collaborative expertise required for study design, data analysis, and contextual interpretation of data that are
required for rigorous, reproducible research that advances scientific knowledge about HIV. The purview and
expertise of Core G faculty and staff includes framing of research questions, study design, sampling,
computation, data analysis (including development of new methods as needed), data management, and
interpretation of analysis results in context. Core G will collaborate with and support HIV researchers and trainees
by meeting the following Specific Aims: (1) providing wide-ranging biostatistical collaboration to CFAR scientists,
with emphasis on early stage investigators; (2) developing, implementing and disseminating new statistical
method to meet the research aims of CFAR scientists; (3) providing ongoing training and mentoring through
workshops and 1:1 mentoring; (4) promoting cross-CFAR, cross-program and international collaborations with
HIV researchers; and (5) providing guidance and support for analyzing and accessing electronic health records
data from Brown- and BU-affiliated hospitals.